Deciphering the function of cohesin and CTCF in R-loop-mediated DNA repair at telomeres

R-loops (RLs) are triple-stranded nucleic acid structures consisting of an RNA-DNA hybrid and a displaced
single-stranded DNA loop. While unregulated RL accumulation causes genomic stress, DNA damage-induced
RLs can also regulate the DNA damage response (DDR). While excessive telomeric R-loop (TRL)
accumulation is linked to telomere shortening, and thus, aging, mechanistic understanding of the function of
TRLs in the DDR at telomeres is limited. Recent findings from our lab and my co-sponsor, Dr. Li Lan (Duke
University), implicate the cohesin-NIPBL complex and its cofactor, CCCTC-binding factor (CTCF), in TRL-
mediated repair at telomeres. Our preliminary atomic force microscopy (AFM) data establishes cohesin and
CTCF as avid R-loop binding proteins, and we show cohesin’s SA2 subunit binds to TRLs. Using a system that
induces site-specific R-loops in a damage-dependent fashion in human cells (KillerRed system), Dr. Lan’s lab
shows that cohesin recruits the RAD51 repair protein to genomic damage sites through R-loops. Additionally,
they show cohesin’s SA1 and SA2 subunits localize to TRLs induced specifically at telomeres. Our preliminary
data raises the possibility that cohesin and CTCF facilitate the telomere DDR by recognizing DNA damage-
induced TRLs and recruiting repair proteins to damaged telomere sites. In this proposed work, I will test this
hypothesis by leveraging a unique combination of in vitro AFM imaging and fluorescence cellular imaging with
the KillerRed system. In Aim 1, taking advantage of the nanometer resolution of AFM, I will characterize the
molecular mechanism by which cohesin and CTCF interact with TRLs by identifying the cohesin subunits
involved in TRL binding and the role of CTCF in TRL localization by cohesin. In Aim 2, I will use a telomere-
specific KillerRed system that induces localized DNA damage and TRLs at telomeres to determine the function
of cohesin and CTCF in TRL-mediated DNA repair at telomeres in human cells. I will determine if damage-
induced TRLs enhance cohesin and CTCF localization to damaged telomeres. Furthermore, I will determine if
cohesin and CTCF recruit repair proteins to damaged telomeres via TRLs using multicolor fluorescence
imaging. I predict that DNA damage-induced TRLs will be resolved upon completion of DNA repair mediated by
cohesin and CTCF, and compromised recruitment of cohesin and CTCF at TRL will lead to DNA repair defects
and TRL accumulation. To test this hypothesis, I will assess if the reduction in cohesin and CTCF levels with
siRNA promotes TRL accumulation. Lastly, persistent telomere damage is known to accelerate telomere
shortening and, with it, cellular aging. I will assess if cohesin and CTCF maintain telomere length in a TRL-
dependent fashion by monitoring telomere lengths in human cells with knockdown of cohesin or CTCF.
Through the proposed work, I will decipher a previously unexplored function of cohesin and CTCF in TRL-
mediated DNA repair at telomeres, opening a new window into the world of telomere instability and aging.

Public health relevance
NARRATIVE Cohesin and its cofactor, CCCTC-binding factor (CTCF), have been shown to 1) localize to telomeres, the protective ends of linear chromosomes, and 2) directly bind R-loops, which promote DNA repair through poorly understood mechanisms. While R-loop accumulation at telomeres is linked to telomere shortening and accelerated aging, many questions remain about how telomeric R-loops are regulated and how they function in the telomere DNA damage response. Based on our recent discoveries of cohesin’s role in R-loop-mediated DNA repair at genomic sites, we will explore a potential functional link between telomeric R-loops, cohesin, and CTCF in the telomere DNA damage response.